NIH-DOD Collaboration for Chemical Threats Affecting the Respiratory System

The project under this IAA has been developed jointly by the NIAID/NIH CCRP and DoD/USAMRICD. Chemical Threats Affecting the Respiratory System will be addressed under the scope of this IAA. This proposed Year 01 of 02 effort directly addresses the need to develop medical countermeasures against chemicals that have identified by the Department of Homeland Security (DHS) as threats to the respiratory system to include chemical warfare agents, pharmaceutical-based agents, and toxic industrial chemical compounds and pulmonary irritants. The research purpose of this interagency agreement includes development of in vitro, in vivo, and/or ex vivo models of the acute and/or chronic long-term toxic effect of exposure to the chemical threats for the purpose of medical countermeasure development. Research under this IAA will focus on toxic chemicals specifically sulfur mustard, phosgene, carfentanil, and other synthetic opioids. The rational development of the mature MCM product to be used as a therapeutic for chemically induced pulmonary injury requires an understanding of the mechanisms of toxicity of lung irritant gas exposure. This IAA may utilize state-of-the-art toxicological, biochemical, physiological, genomic and electron microscopic evaluation approaches to elucidate the molecular mechanism to support the efficacy testing.